MOLECULAR PATHOGENESIS OF CHANCROID

DESCRIPTION (Adapted from applicant's abstract): Chancroid, an ulcerogenital disease caused by the fastidious gram-negative bacterium Haemophilus ducreyi, is one of the least understood sexually transmitted diseases. The association between genital ulcer disease and transmission of HIV makes control and prevention of chancroid a public health concern. The ultimate goals of this research project is to identify bacterial products that could serve in a vaccine. The applicant has developed model systems for studying virulence of H. ducreyi, including a temperature-dependent rabbit model for studying dermal lesions and a human foreskin fibroblast (HFF) for cell culture studies. Moreover, the applicant has developed a generalized mutagenesis system for this pathogen and interesting mutants have been isolated and characterized. The applicant proposes to use the mutagenesis system to identify and characterize mutants that are unable to adhere and/or form microcolonies on HFF cells. The applicant will also investigate a cytolethal distending-like toxin and other extracellular proteins for their role in virulence. Mutants with altered lipooligosaccharide will be isolated and characterized and examined for their virulence properties. Selected mutants will be compared to the parental strain in a human infection model.